Administrative Core

PROJECT SUMMARY/ABSTRACT
Administrative Core (Core A)
Administrative and fiscal management and oversight of the Harvard University Center for AIDS Research (HU
CFAR) is the primary charge of the HU CFAR Administrative Core. The main objectives of the Administrative
Core are:
· To oversee and direct the HU CFAR strategic planning process that guides decision-making relevant to
the goals of the Scientific Working Groups and Scientific Programs, and the allocation of resources within the
HU CFAR via clear evaluation criteria;
· To provide HU CFAR members access to scientific initiatives, resources, information and Core services
which foster collaborative, multidisciplinary research;
· To develop and implement clear and reasonable policies and procedures for the operation of, and
access to, Core services and resources, and;
· To provide fiscal oversight and guidance to the sub-recipient institutions and agreements necessitated
by the developing collaborations among domestic and international institutions, all of which are
administratively, fiscally and geographically distinct.
The Administrative Core coordinates and manages all inter-institutional HU CFAR activities conducted across
the HU CFAR-participating institutions. The goal of the HU CFAR is to promote and encourage interactions
among researchers at these institutions, specifically among young investigators, underrepresented groups in
research, and women, and to facilitate the transfer of new HIV/AIDS treatments from the laboratory into clinical
testing and translational research.